Evaluation of Prg4 as a New Therapy for TMJ Disc Degeneration

The temporo-mandibular joint (TMJ), composed of the mandibular condyle, the glenoid fossa of the
temporal bone and the articular disc, is essential for speech and mastication. The disc plays an important role
in TMJ movement, by allowing the condyle to freely slide down the slope of the glenoid fossa. TMJ disorders
(disruption in the structure, function or physiology of the TMJ) afflict approximately 20% of the U.S.
population, and up to 70% of the conditions are due to TMJ disc displacement and/or damage. It is generally
believed that aberrations in the lubrication system, which depends primarily on joint lubricants, including
hyaluronic acid, phospholipid, and Proteoglycan 4 (Prg4), contribute to TMJ dysfunction. A critical gap in
knowledge is to clarify the extent to which joint lubricants establish and maintain the structure and function of
the TMJ disc. We found that TMJs of Prg4-null (Prg4-/-) mice exhibited significantly greater degenerative
changes compared to other synovial joints, including the knee. We found in Prg4-/- mice that: (a) the TMJ
discs failed to develop their biconcave shape and became substantially thickened over time; (b) a large number
of the disc cells differentiated into fibrochondrocytes, leading to disc mineralization; and (c) subsequently, the
condylar cartilage broke down and the trabecular bone exhibited architectural changes. In addition, the
mechanical properties of the Prg4-/- discs were significantly altered compared to controls. These and other
novel data lead to our central hypothesis that Prg4 is necessary: 1) to maintain TMJ disc cell phenotype and
function, and 2) to protect the TMJ from degenerative changes. In Aim 1, we will determine the signaling
pathways, by which PRG4 regulates region- and stage-specific phenotypes of disc cells across multiple
anatomical sites, and elucidate how global loss of Prg4 leads to abnormal disc cell function and disc zonal
organization. By inducing cell death in Prg-4 expressing cells postnatally, we will also define the roles of Prg4-
expressing cells in disc morphogenesis and homeostasis. In Aim 2, we will test if TMJ disc degeneration is
treatable, and, if so, also determine if there is a therapeutic window for successful intervention. We will restore
Prg4 expression postnatally via virally-driven overexpression of Prg4 and tamoxifen or virally-driven Cre
recombinase in ROSA26CreERT2;Prg4GT (Prg4cGT) mice, which have a reversible gene-trap (GT) in Prg4
(Prg4GT), in which Prg4 expression is activated upon Cre-mediated excision of the gene-trap. Phenotypic
analyses will include histopathology, gene and protein expression, and biomechanical tests. Orofacial pain will
be evaluated by mechanical reflex testing and rodent grimace scale. Our project will provide novel and far-
reaching information regarding the role of joint lubricants in TMJ disc maintenance and disease. Our rescue
experiments should provide a proof-of-principle that TMJ disc degeneration is amenable to therapeutic
intervention. While our experiments use the TMJ as a model system, we believe results from this application
will also be directly applicable to other synovial joints.

Public health relevance
Narrative: The articular disc of the temporomandibular joint (TMJ) plays an essential role in TMJ functions during mastication and speech, but when damaged, can hinder quality of life of the patient. This grant aims to address the unmet medical needs for treatments of damaged TMJ discs. The goals of this project are: 1) to define the function of Prg4 in TMJ disc morphogenesis and in disc cell phenotype and function, and 2) to test if Prg4 restoration ameliorates or prevent TMJ disc degeneration.